Development of multi-modal single-cell technology to dissect epitope specificity to HIV

ABSTRACT/SUMMARY:
Single-cell genomic technology is transforming modern immunology. Single-cell transcriptomic
profiling combined with DNA bar-coding technology is capable of acquiring information on multiple
modalities simultaneously; surface receptor quantitation, paired clonotype identity, and genotype
can now be measured alongside the transcriptome in relatively routine technology. Extending this
rapid technological development in single-cell genomics, it is now possible to probe epitope-
specificity of individual antigen-specific cells in a high-throughput fashion. The goal of this
proposal is to apply DNA bar-coding technology to build reagents capable of assessing B and T
cell specificity to HIV epitopes alongside other single-cell cell readouts, and in a high throughput
manner. The development of technology capable of rapid resolution of epitope specific responses
would address several needs in HIV research: (i) it would greatly accelerate the discovery of novel
broadly neutralizing antibodies against HIV; (ii) it would allow comprehensively profiling of T cell
HIV epitopes, allowing more rapid identification of epitopes associated with protective immunity;
(iii) it would characterize transcriptional states of HIV-infected cells and accurately assess
differences between productively-infected, latently-infected and uninfected bystander cells. In the
incumbent grant (i.e. prior funding period), we developed novel methodology to obtain paired
clonotype identity and transcriptome data in antigen-specific B cells, including development,
validation and benchmarking of a novel bioinformatics algorithm capable of accurately
reconstructing paired immunoglobulin gene sequences in vaccine-elicited B cells. Here, we
extend our prior work to incorporate additional information: antigen specificity for HIV epitopes.
We will use DNA bar-coding technology to develop reagents capable of resolving epitope-
specificity of HIV-specific B and T cells in a high throughput fashion. Specifically, we will apply
DNA-bar codes to native HIV trimers and gp120 monomers to accelerate identification of B cells
producing neutralizing antibodies. We will also develop DNA bar-coded tetramer-based
technology to massively profile HIV-specific T cell responses epitope resolution. Lastly, we will
build on our ability to simultaneous quantify viral genomes and host cell transcriptome data in
single cells and develop methodology to differentiate the transcriptomes from latently-infected,
productively-infected, and uninfected bystander cells in HIV infection. These technologies would
be broadly applicable to HIV research and would provide high throughput means to identify
correlates of protection in several advanced HIV vaccine platforms.

Public health relevance
NARRATIVE: This technology development proposal will develop novel tools to study immune responses against HIV at the single cell level. Specifically, this work will use DNA-bar-coding methodology to build reagents capable of resolving immune responses to differing molecular structures of the HIV virus. These methods will accelerate the discovery of effective antibodies against HIV, and enable rapid identification of structures of the virus against which the immune system is most effective.